Equitable Implementation of Remote Patient Monitoring in Pediatric Invasive Home Mechanical Ventilation Using Wireless Devices

PROJECT SUMMARY/ABSTRACT
Children who use invasive home mechanical ventilation (IHMV) are a growing population of pediatric
patients with severe bronchopulmonary dysplasia, lung or airway malformations, or neuromuscular conditions
affecting respiration who are reliant on positive pressure ventilation delivered through a tracheostomy for long-
term respiration. Despite IHMV providing a life-sustaining bridge for these children to live at home, IHMV
includes risk of death from ventilator malfunction, high family caregiver burden, and high home healthcare
costs estimated at ~$20,000/month/child. Therefore, to optimize IHMV, clinicians routinely assess whether to
titrate up or down a patient’s level of positive pressure support and/or hours/day on the home ventilator to
maintain respiratory stability while also balancing IHMV health risks, caregiving breaks, and long-term costs.
To date, no evidence-based approaches exist for pediatric chronic IHMV management, resulting in high-
clinical variability and disparities for Hispanic/Latinx patients. Currently, in-person cross-sectional assessments
are used to optimize ventilator settings but provide only a limited picture of a child at home. As a novel
alternative, we co-designed a remote patient monitoring dashboard that links parents’ hand-collected vital
sign data and parent-reported symptoms to the children’s electronic health record, that can be trended by the
clinical team to facilitate more informed, remote chronic ventilator changes. However, key limitations to this
current approach include: 1) the time and cognitive burden of hand-collected data by parents and 2) lower
usability with hand-collected data entry in parents with a language other than English and/or lower technology
literacy, which raises concerns about equitable implementation of this new dashboard across diverse families.
To address our prior limitations, this R03 will: 1) validate the use of soft, flexible, skin-attached
biosensors and a portable capnograph to wirelessly collect continuous physiologic data as an alternative to
hand-collected vital sign data collection by parents (Aim 1) and 2) apply the Health Equity Implementation
Framework using contextual qualitative interviews to identify determinants (barriers and facilitators) of remote
monitoring use and implementation strategies that could increase use of this intervention in populations at risk
of lower adoption (Aim 2). Together these Aims will provide essential data for more effective and equitable
implementation of our remote patient monitoring intervention in a larger multisite clinical trial, which will be a
paradigm shift in chronic home ventilator management. This work is significant in developing critically
needed evidence-based strategies that provide effective and family-centered pediatric care for children with
medical technology dependence, in a manner that will ensure no children and their families will be left behind.

Public health relevance
PROJECT NARRATIVE The healthcare system does not currently provide convenient, evidence-based ways for clinicians to adjust ventilator settings for children who use them for respiratory support at home, leading to inconsistent and unequal outcomes across this population of children. This project will try to find out whether wireless devices can provide a better, more family-centered way to share information about how a child is doing at home so that clinicians can safely adjust ventilator settings remotely, without the need for in-person assessments. This research will also find ways to make sure that this sort of remote care can be used in children living in families with different backgrounds and resources, to make sure that all possible children can benefit, no matter where they call home.